Discovery of osteoblast and osteoclast bone mass effector genes using advanced genomics

Osteoporosis is a devastating disease of bone that impacts over 10 million Americans. While the cellular basis
for osteoporosis includes an imbalance in bone formation by osteoblasts and bone resorption by osteoclasts,
there are relatively few validated, clinically relevant genes directly linked to osteoporosis. There is a significant
need to discover new genes that influence osteoporosis pathogenesis. Discovery of new osteoporosis genes
will eventually permit the field of bone and mineral biology to achieve the long-term goal of developing new
therapies to both prevent and treat this debilitating disease.
The existing, long-term collaboration between the Hankenson and Grant laboratories has been focused on
understanding the functional significance of genome wide association study (GWAS) signals associated with
bone mass, osteoporosis and fracture risk. We have developed methods to use those signals to identify novel
genes putatively involved in disease pathogenesis. While GWAS efforts by numerous research groups have
been successful in discovering genomic variants robustly associated with bone mineral density (BMD) and
fracture, GWAS only reports signals associated with a given trait and not necessarily culprit genes.
In this proposal we utilize a computationally advanced, multi-step process that integrates genome level data to
identify novel osteoblast and osteoclast genes. This bioinformatically-driven `genome-wide variant to gene
mapping' effort combines RNA-seq, ATAC-seq and high-resolution chromatin conformation capture methods to
implicate culprit effector genes. We have already used this approach in osteoblast lineage cells and 30% of
osteoporosis-associated GWAS signals were shown to have direct physical contact with genes in these cells,
totaling 86 putative target genes. Several of these targets (ex. EPDR1, ING3) have already had extensive
functional follow-up. However, many more need functional follow-up and there are still 70% of osteoporosis
associated GWAS loci that remain unresolved. Importantly, our initial work focused only on discovering
osteoblast-associated genes, and thus genes that play a role in osteoclasts were not revealed. Furthermore,
our published work to date has only focused on one time-point during the osteoblast differentiation process,
thus genes that play roles at later points in cell differentiation have not been discovered.
This comprehensive application will functionalize GWAS findings, and in doing so, reveal novel genes involved
in regulating bone formation and resorption. Our established pipeline from gene discovery to gene validation
has been robustly tested and thus far, although our sampling has been small, we have had a 100% hit rate for
validating putative effector genes. Thus, it is our hypothesis that we can uncover many more BMD effector
genes by conducting high resolution `genome-wide variant to gene mapping' in osteoclasts and osteoblasts.
The relevance of genes will be validated using both in vitro and in vivo approaches in mouse models. Upon
completion, we will provide the bone community with new targets to pursue for understanding mechanism.

Public health relevance
Genome wide association studies (GWAS) have revolutionized the field of complex disease genetics. Intense efforts by large-scale international collaborations, including ours, have been successful in discovering key genetic variants robustly associated with bone mineral density (BMD) and fracture; however, GWAS only reports genomic signals associated with a given trait and does not necessarily identify culprit effector genes. Given the need for `variant to gene mapping', plus the need to expand the collection of public domain genomic data relevant to bone, we will build on our initial published results by utilizing our multi-step genomic analysis pathway and functional follow-up using siRNA and CRISPR in osteoblasts and osteoclasts and knockout mouse models to pinpoint causal gene(s) at key BMD and fracture GWAS-implicated locus.